MEDICAL WRITING CONSULTING SERVICES

The NIH is seeking senior-level, industry-experienced drug discovery and development consultants with expertise in the following specific disciplines to provide leadership and technical guidance on drug discovery and development projects in the ultra-rare gene-based therapy (URGENT) program. The area of expertise needed in medical writing.